Novel Approach to 24-hr IOP Assessment

PROJECT SUMMARY
Twenty-four-hour intraocular pressure (IOP) assessment remains an unmet need in the clinical management of
glaucoma. Among the devices that yield IOP measurements in millimeters of mercury, there is a 15-33% variance
between true IOP and device output. Other devices lack the automation that facilitates IOP capture during
undisturbed sleep. The ideal device would be non-invasive, accurate, and automated. Such a device would
permit the exploration of the relationship between intraday IOP fluctuation and the pathogenesis of Primary Open
Angle Glaucoma, the leading cause of irreversible blindness. It would also facilitate accurate screening, rapid
diagnosis, and intuitive assessment of response to treatment. The overarching goal of the proposed research
is to develop an accurate, safe, wearable IOP monitor. To accomplish this, we propose the following aims:
Aim 1: Develop prototype of a contact lens based IOP sensor based on Atomic Force Microscopy.
Aim 2: Develop an empirical model for the relationship between indentation measurements and IOP.
Aim 3: Assess the effects of self-sensing cantilever indentation on the human corneal epithelium.
The results of these experiments will inform prototype development with the goal of developing a wearable IOP
monitor that accurately measures IOP with 0.1-1 mmHg precision. This instrument would improve the clinical
management of glaucoma.
ACTIVITIES RELATED TO DIVERSITY: THE RABB-VENABLE EYE RESEARCH CLUSTER INITIATIVE
Recent studies have demonstrated the dire lack of diversity among ophthalmology faculty and trainees. There is
a similar trend in the biomedical research workforce and the NIH clinical research training program only yielded
five potential eye researchers in 15 years. During the grant funding period, we would like to:
Objective 1: Expand URiM medical student recruitment to ophthalmology residency training programs.
Objective 2: Support URiM medical students to complete a one-year research fellowship.
Objective 3: Increase URiM ophthalmologist representation in the clinical translational research pipeline.
Physician workforce diversity is a key component of mitigating healthcare disparities. This program will produce
up to 25 potential eyes researchers during the 5-year funding period. We believe that building a core of physician
scientists who can provide culturally sensitive care to underserved communities and lead the development and
adoption of equitable healthcare delivery procedures and practices is necessary in ensuring greater health
equity.

Public health relevance
PROJECT NARRATIVE Relevance to public health: Glaucoma is the leading cause of irreversible blindness and will affect nearly 5 million Americans and 112 million people worldwide by 2040. This project seeks to develop an accurate and automated wearable IOP monitor based on Atomic Force Microscopy nanoindentation capable of accurately assessing physiologic IOP fluctuation; this device will significantly improve access to glaucoma care and the efficiency of the clinical management of glaucoma. The Eye Research Cluster Initiative is an extramural training program that will expand and strengthen a more diverse vision research workforce in compliance with the 21st Century Cures Act.